Responsible Conduct of Research Training in Biomedical Data Science for Dental, Oral and Craniofacial Research

PROJECT SUMMARY/ABSTRACT
This R25 educational project proposes to develop a set of training modules for starting oral biology
research fellows and dental specialty residents. The proposed modules will introduce the training in
Responsible Conduct of Research focusing on biomedical data science in the field of dental, oral and
craniofacial research. With the advent of the rapid development of research technologies, the past decade has
seen vast accumulation of acquired data on human health and diseases. The biomedical data science is a new
research discipline to best analyze the massive biomedical data sets to discover new knowledge about the
function and mechanism of our health and disease, which is highly relevant to our future professionals in
scientific research and clinical dentistry.
Specific challenges in biomedical data science include the appropriate data curation system handling
the datasets in a FAIR (Findable, Accessible, Interoperable, and Reusable) manner; the standardized scientific
workflow systems to capture the provenance of data transformations; and the ethical challenge in dentistry for
privacy, anonymity, security and informed consent using digital, electronic and mobile health records. The
proposed educational modules will discuss these challenges in real life scenarios through an extended
massive online course (xMOOC) format.
Aim 1: The PD/PI will form the WORKING TEAM of committed faculty to [1] curate a bank of highly
relevant case series with content advisors who are established in dental, oral and craniofacial research as well
as biomedical data science; [2] design and develop case studies and problem sets; and [3] construct video
clips with UCLA Instructional Media Production. Aim 2: The PD/PI and the WORKING TEAM will [1] establish
the 5-module xMOOC training program; [2] develop forums and case discussion programs; and establish self-
test problems. UCLA Center for Advancement of Teaching (CAT) is the campus resources assisting this
process. Aim 3: The PD/PI and the WORKING TEAM will [1] initiate the pilot test with invited trainees; and [2]
analyze the evaluation matrix and make necessary revisions.
To succeed the development of the training module, the PD/PI and the WORKING TEAM will be
supported by the educational program advisors and the content advisors solicited throughout from the rich
research environment of UCLA. The Dean of UCLA School of Dentistry is committed to support this program
development.
Finally, the final version of the training module will be professionally evaluated by UCLA Center for the
Advancement of Teaching, and disseminated through a non-profit MOOC provider and submitted to NIGMS.

Public health relevance
NARRATIVE With the advent of the rapid development of research technologies, the past decade has seen vast accumulation of acquired data on human health and diseases. The objective of this R25 educational project is to design, develop and implement the new training modules addressing the Responsible Conduct of Research in Biomedical Data Science for Dental, Oral and Craniofacial Research.